Proactive Management to Improve Laboratory Macaque Breeding Colony Health and Well-being

Project Summary
This study will advance the current understanding of how management procedures that involve predictability,
opportunity and control can be implemented proactively to accomplish meaningful reductions in stress, social
aggression and trauma that generate a net cost savings for the CNPRC (and other primate facilities). Our
investigation of social network structure and dynamics using novel network measures and techniques will allow
us to gain a deeper understanding of whether/how these management strategies accomplish such reductions
in stress and trauma, such as offering methodologies for examining the complexity of social stability, and our
utilization of a thorough economic approach to calculate all costs associated with implementation of
management procedures will allow us to conclude with certainty which management strategies reduce
hospitalizations due to stress and trauma with minimal increases in staff time to yield significant cost savings
for the CNPRC (and other primate facilities), and ultimately improve animal health and well-being in a cost-
effective fashion.

Public health relevance
Project Narrative This study will advance the current understanding of stress and deleterious aggression in captive nonhuman primates using an experimental social network approach that will allow the development of an adaptive management program for primate facilities that will enhance group stability and successfully reduce stress and deleterious aggression, and prevent severe outbreaks in group-housed rhesus macaques. The rhesus macaque is an important biomedical model for human health research and this research is relevant by addressing the 3R's and their effects on biomarkers of individual health in a well-established nonhuman primate model.